Characterizing the mechanism of loss-of-function mutations in ALPK3 in the pathogenesis of cardiomyopathy

PROJECT ABSTRACT Cardiomyopathies are a broad spectrum of diseases that alter the morphology of the heart muscle. A significant portion of previously unexplained cardiomyopathies are now understood to be the result of mutations in genes that are highly expressed in the heart. Even for patients with other common causes of heart failure such as hypertension or coronary artery disease, genetic variants in cardiomyopathy-associated genes can individually or collectively affect cardiac morphology and influence disease severity. Thus, a mechanistic understanding of the genetic causes of cardiomyopathy can reveal regulators of cardiac remodeling, a critical first step for the development of therapeutics to attenuate these processes. Studies of patients with inherited forms of cardiomyopathy have revealed monogenic mutations in genes that encode components of the sarcomere — the contractile apparatus of a cardiomyocyte. Mutations in these sarcomeric components can impair the ability of the cardiomyocyte to contract and relax normally, and ultimately result in pathologic remodeling and heart failure. Recent exome sequencing studies, conducted by our lab and others, have identified a novel cardiomyopathy-causing gene called ALPK3. Unlike most known cardiomyopathy genes, which encode components of the sarcomere, ALPK3 encodes a muscle-specific kinase that is localized to the nucleus. Therefore, understanding the function of this kinase has the potential to reveal novel signals from the nucleus that profoundly impact cardiomyocyte biology. I have created human isogenic induced pluripotent stem cell derived cardiomyocytes (hiPSC-CMs) with and without ALPK3 mutations to interrogate the molecular pathways in which this kinase participates, and the mechanisms by which ALPK3 mutations result in cardiomyopathy. These studies are predicated on the hypothesis that ALPK3 mutations deplete kinase activity and/or critical protein-protein interactions that lead to dysregulated cellular signaling and culminate in contractile dysfunction. I will address this hypothesis with three specific aims: Aim 1. Identify substrates of ALPK3 kinase activity and ALPK3 protein-protein interactions. Aim 2. Characterize the effects of ALPK3 loss-of-function mutations on the cardiomyocyte transcriptome and proteome. Aim 3. Determine the functional effect of ALPK3 loss-of-function mutations on sarcomere dynamics. Collectively, these studies will provide new genetic, mechanistic, and functional insights into the role of ALPK3 in cardiac physiology and disease. !

Public health relevance
PROJECT NARRATIVE Cardiomyopathy, a disease in which the chambers of the heart become enlarged, results in heart failure, the leading cause of death in the United States. This project interrogates the effects of mutations in ALPK3, a nuclear cardiomyopathy gene, using human induced pluripotent stem-cell-derived cardiomyocytes (hiPSC-CMs) and murine models. These efforts will define novel regulators of cardiac remodeling for therapeutic intervention. !